Neural basis of visual attention in the primate brain

PROJECT SUMMARY
Natural scenes are cluttered with multiple objects that compete for neural representation due to limited
processing capacity. Mechanisms for selective processing, broadly referred to as visual attention, are therefore
needed to prioritize relevant stimuli. Classic studies of spatial attention have largely ignored its temporal
dynamics, assuming that associated neural and behavioral effects were continuous for the duration of attentional
deployment. Recent studies, however, have provided compelling evidence, in both humans and monkeys, that
spatial attention fluctuates over time, sampling the environment in theta-rhythmic cycles (~4-8 Hz), associated
with alternating periods of either enhanced or diminished perceptual sensitivity. We have begun to uncover the
neural basis for the rhythmic properties of spatial attention, both in humans and monkeys, across the large-scale
network that subserves attention. We found that the phase of intrinsic theta rhythms across fronto-parietal cortex
and, in macaques, also in the pulvinar, predicted behavioral outcome. Neural evidence suggests that theta
rhythms organize neural population activity into two alternating states: One that promotes sampling visual
information from the presently attended location, and another one that promotes shifting attention to a new
location in the visual field. We have synthesized our findings and previous evidence into a novel framework, a
rhythmic theory of attention. Based on this framework, our central hypothesis for the proposed project is that
low-frequency rhythms serve as a clocking mechanism to coordinate sensory and motor processes in the
attention system and that these rhythms flexibly adjust to changing behavioral demands (e.g., varying cueing
context). Using identical attention tasks in humans and macaques, we will establish common behavioral patterns
and relate them to intracranial neural activity in both species. This approach aids in developing models for human
brain function, bridging the mesoscopic level of human intracranial EEG to cell-type specific neural population
dynamics (e.g., laminar recordings) and causal manipulations (e.g., electrical microstimulation) obtainable in an
animal model. Further, our studies will be among the first to record from the human thalamus. We will use
‘behavior-as-glue’ to guide our comparison of neural mechanisms across primate species and levels of analyses.
Specifically, we will (i) investigate mechanisms for coordinating functional conflicts between visual and motor
processes across the human brain and in functionally specialized populations of neurons in macaque FEF, LIP
and pulvinar, (ii) investigate mechanisms for fronto-parietal and thalamic control in organizing visual processes
(including in macaque V4 at the laminar level), and (iii) investigate a causal role for pulvino-cortical interactions
in shaping attention behaviors. Impairments of selective attention have devastating consequences on human
health (e.g., after stroke, and in neuropsychiatric diseases, such as schizophrenia). The significance of the
proposed research is that it will test hypotheses from a novel and potentially paradigm-shifting framework using
innovative and cutting-edge approaches at the level of cognitive large-scale networks and linked to behavior.

Public health relevance
PROJECT NARRATIVE The proposed research aims to advance our understanding of how the brain prioritizes information from cluttered visual environments to guide ongoing behavior. This process, broadly referred to as selective attention, is impaired in several clinical populations, including individuals with spatial neglect after stroke, attention deficit hyperactivity disorder (ADHD), schizophrenia, and autism spectrum disorders (ASD). By better understanding the separable neural processes that contribute to selective attention, we hope to generate more pointed hypotheses about its dysfunction, leading to more effective treatments and interventions.